OPAL Center Administrative Core

The Administrative Core works to maximize the impact of the OPAL Center's work. The Administrative Core
supports and coordinates the efforts of all investigators and units to create synergies among the Center's
activities. The Core fosters interdisciplinary collaboration, manages the pilot project program, supports training
opportunities, monitors Center activities and progress, plans for future research projects, and disseminates
information about the Center and the results of its efforts. The OPAL Center's Administrative Core
accomplishes these goals through the following activities:
1. Support Center activities to facilitate innovative, transdisciplinary translation research that will lead to
improved treatments, services, and outcomes for individuals diagnosed with schizophrenia. The Administrative
Core provides administrative support to the Methods Core, all research projects, the Scientific Steering
Committee, and the Stakeholder Advisory Boards.
2. Ensure stakeholders participate in Center research projects from conception to study conduct to
interpretation and dissemination of study findings. We are enhancing stakeholder involvement based on our
values and on important contributions from our national stakeholders and from local provider and consumer
stakeholders on our ongoing and planned work.
3. Foster interdisciplinary synergies among research disciplines and the Center's cores. The Administrative
Core fosters communication among its investigators and communicates about administrative needs.
4. Solicit, select, and support pilot projects. The OPAL Administrative Core solicits applications for a
competitive process to conduct Center-funded pilot studies, each including early-career investigators, that
extend its scientific reach and draw upon Center resources and synergies.
5. Support training opportunities. OPAL trains researchers to conduct T2 translational research that focuses
on improving treatments, services, and their delivery, with a goal of improving patient-centered outcomes in
schizophrenia.
6. Communicate OPAL's aims and activities and disseminate information about the Center and the results of
its efforts. The Administrative Core uses multiple channels to communicate about its activities and research
findings.
7. Monitor and evaluate center progress. The Administrative Core will oversee evaluations of each project,
the Methods Core and its Units, and of the overall Center.
8. Plan future projects. The Administrative Core will work with the Scientific Steering Committee to identify
important issues and research questions and facilitate development of projects to address these questions.